ACCESS: Accelerating Cervical Cancer Elimination through the integration of Screen-and-treat Services

PROJECT SUMMARY
My proposal is a submission in response to the Notice of Special Interest (NOSI) identified as NOT-CA-23-038.
I am an Assistant Professor of Medical Sociology and Anthropology and a Research Fellow at the Center for
Translation and Implementation Science (CTAIR) at the University of Nigeria, Nsukka. My research focuses on
palliative care (PC), cancer and women’s health in low- and middle-income countries (LMICs). This
administrative supplement mentor award will provide me with the support needed to achieve the following 3 key
career development objectives for research in LMIC settings: (1) Sharpen my skills in community based
participatory research, stakeholder’s engagement and program integration especially in PC clinical settings; (2)
Acquire in-depth knowledge of implementation frameworks and methods to help close the gap between
implementation science and implementation practice; (3) Acquire skills and content expertise in PC research. I
will conduct research and work with my mentors for a minimum of 40% of my time within the Nigerian
Implementation Science Alliance-Model Innovation and Research Centers (NISA-MIRCs), a practice-based
research network across the six geographical regions in Nigeria. To accomplish these objectives, I have put
together a mentoring team including: (1) a US Primary Mentor, Prof. Gregory Aarons from University of California,
San Diego who is an expert in Implementation Science; (2) a LMIC Primary Mentor, Prof. Echezona Ezeanolue
from the University of Nigeria, who is an expert in community-based participatory research and clinical research;
(3) a LMIC Co-Mentor, Dr Tonia Onyeka from University of Nigeria Teaching Hospital [UNTH], who is an expert
in PC research and practice; (4) a LMIC Peer-Mentor, Dr John Olawepo from Center of Translation and
Implementation Research [CTAIR], who is an expert in health systems integration. My team of mentors will
support my capacity building and research project, which includes a pilot study to explore the feasibility and
acceptability of a culturally adapted and integrated PC package to promote wellbeing of women living with HIV
(WLHIV) and cervical cancers. My specific aims are to: (1) Co-create and develop feasible, culturally adapted,
and sustainable PC service package with WLHIV and cervical cancer from the NISA-MIRCs. We will adapt core
elements of PC services recommended in the National Comprehensive Cancer Network (NCCN) guideline using
well-established mixed method approaches; and (2) Pilot the adapted multicomponent PC package to determine
feasibility and acceptability at two NISA-MIRCs facilities. During the year of this administrative award, my Nigeria-
and US-based mentors, co-mentor, and peer-mentor will provide additional training and guidance in their areas
of expertise including implementation science, community based participatory research, PC, and health systems
integration.

Public health relevance
PROJECT NARRATIVE While Palliative Care (PC) is a key component of the comprehensive cancer control program, major challenges remain in making PC services accessible in low- and middle-income countries (LMICs). PC services remains underdeveloped and limited in scope and practice within Nigeria. In this study, we aim to develop and explore the feasibility and acceptability of a culturally adapted and integrated PC package to promote wellbeing of women living with HIV and cervical cancers.